Inhibition of NLRP3 inflammasome for the treatment of Chemotherapy-induced peripheral neuropathy

Summary
Paclitaxel is a drug commonly used for the treatment of breast, lung, and ovarian cancer. Chemotherapy-
induced peripheral neuropathy (CIPN) is one of the most common and serious adverse effects experienced
by cancer patients treated with paclitaxel. CIPN can be a dose-limiting factor for chemotherapy, leading to
premature termination of treatment, thereby influencing survival and quality of life. Currently, no therapies
have been identified that address the underlying pathogenic mechanisms of CIPN. Therefore, the
identification of alternative forms of therapy is a crucial medical need. This proposal focuses on a promising
target: NLRP3 (which encodes NOD-, LRR- and pyrin domain-containing protein 3) inflammasome. Our
preliminary data suggest for the first time that NLRP3 inflammasome contributes to CIPN produced by
paclitaxel in mice. Paclitaxel treatment increased the expression levels of NLRP3, caspase-1 and IL-1β in
the dorsal root ganglia (DRG) of mice. Furthermore, paclitaxel-induced neuropathic symptoms were
completely absent in null mice lacking NLRP3 compared to wild type mice. Collectively, our preliminary
results suggest that NLRP3 inflammasome inhibition represents a promising novel strategy for the treatment
of CIPN. This project will test the central hypothesis that NLRP3 inflammasome activation contributes to
paclitaxel-induced CIPN and that inhibition of NLRP3 inflammasome alleviates these effects. The main goal
of the project is to determine whether dapansutrile, an oral selective NLRP3 inflammasome inhibitor currently
in phase II clinical studies for the treatment of gout flares, alleviates and prevents paclitaxel-induced CIPN in
a mouse model of naïve and tumor-bearing animals. We will determine the effects of dapansutrile after acute
and chronic oral administration in mice treated with paclitaxel and cisplatin. We will then determine if
dapansutrile reverses ongoing pain of paclitaxel-induced CIPN by capturing the motivation to seek relief
using the conditioned place preference (CPP) test. Finally we will address if dapansutrile treatment would
prevent CIPN while enhancing or at least not interefering with anti-tumor efficacy of paclitaxel in tumor-
bearing mice. If successful, our project will provide a rationale for development of NLRP3 inflammasome-
based medications to treat this side effect of cancer chemotreatment.

Public health relevance
Narrative Chemotherapy-induced peripheral neuropathy (CIPN) is a common and often dose-limiting complication of cancer therapy utilizing taxanes, platinum-based drugs and newer agents such as bortezomib. Currently, no clearly effective therapies exist for prevention or treatment of CIPN. This proposal focuses on preclinical validation of dapansutrile, an oral selective NLRP3 inflammasome inhibitor, as a potential strategy to alleviate and prevent paclitaxel- and cisplatin-associated painful CIPN.